Biostatistics, Epidemiology, and Bioinformatics Core (BEBiC)

Specific Aims: ¿ provide research support in the methodology of the research projects related to the U54 grant ¿ evaluate new methodological approaches in cancer research, and, ¿ mentor training core personnel